Quantitative Analytics and Data Management

RCB PROJECT SUMMARY
The proposed program project, Deploying High Value Longitudinal Population-Based data in Dementia
Research (DEVELOP AD RESEARCH), will leverage two national, longitudinal, population-based studies, the
Health and Retirement Study (HRS) and the National Health and Aging Trends Study (NHATS), both of which
are linked to Centers for Medicare and Medicaid Services (CMS) claims and assessment files, to expand our
understanding of the longitudinal course of dementia and the complex interactions of medical, social, and
health system factors. Research Core B (RCB) – Quantitative Analytics and Data Management will support
the goals of the P01 and its five research projects through four specific aims: 1) To consolidate HRS, NHATS,
and linked CMS database management activities to promote scientific rigor and efficiency throughout the P01;
2) To build the processes and infrastructure, including staff and investigators, to maximize efficient and
synergistic application of our knowledge and resources; 3) To provide state-of-the-art quantitative analytic
support for research projects; 4) To create and disseminate a library of publicly available web-based technical
assistance material to advance geriatric palliative care and dementia research. Comprised of scientists from
the University of California San Francisco and the Icahn School of Medicine at Mount Sinai, the core creates a
transdisciplinary research team of clinician scientists, health services researchers, economists,
epidemiologists, and biostatisticians with expertise in the novel and complex programming, analytic tools, and
statistical methods that are required to effectively use the HRS and NHATS datasets to examine the complex
issues that arise across the disease course from dementia diagnosis to death and provide answers to relevant
clinical and policy questions in dementia care. RCB is the means through which synergies and efficiencies in
quantitative analytic expertise and database management will be achieved in order to successfully complete
the proposed work in each research project. RCB leaders, Drs. Boscardin and Kelley, have the expertise and
experience to accomplish the RCB’s aims through active collaboration with research project investigators,
consultants and analytic staff - all of whom have extensive expertise in managing and analyzing Medicare
linked HRS and NHATS data. RCB will consolidate database management activities by centralizing
administrative and regulatory functions; creating and cataloging a unified set of variables to be used by all
research projects, merging and cleaning datasets needed for the individual research projects including creating
longitudinal hierarchical datasets for analyses, and performing all associated documentation.